Greater Southern California Node of the Clinical Trials Network

Project Summary/Abstract
The overarching goal of the Greater Southern California Node (GSCN) of the National Drug Abuse
Treatment Clinical Trials Network (CTN) is to expand access to and improve outcomes of treatments for
substance use disorders (SUDs)—with a special emphasis on opioid use disorder (OUD) —by collaboratively
developing and testing effective and sustainable interventions for OUD that can be delivered in diverse
healthcare settings. To achieve this goal, we have assembled (1) local, regional, and state-wide healthcare
networks that serve millions of individuals, (2) investigators who have conducted seminal work on development
and testing of pharmacological and behavioral interventions for SUDs, and (3) researchers with expertise in
implementation strategies, data science, and innovative technologies to support treatment delivery and related
research. Building upon investigators' past and current efforts, the specific aims of GSCN are: Aim 1. Lead
and contribute to the development of new research protocols designed to increase access to treatments for
OUD and to improve treatment outcomes; Aim 2. Support and participate in multi-site CTN projects and other
CTN activities; and Aim 3. Disseminate research findings and provide innovative training to impact clinical
practice. The GSCN research agenda will initially focus on four priority areas: (1) developing and testing
effective medication and behavioral interventions for OUD and related comorbidities, (2) applying
implementation science to deliver and expand OUD treatment in multiple healthcare settings, (3) leveraging
eHealth (e.g., electronic health record systems) and data science for discovery and generation of innovative
hypotheses and approaches to improve treatment for OUD, and (4) building on mHealth (e.g., smartphone-
assisted interventions) and other technologies (e.g., telemedicine) to expand OUD treatment access and
utilization. The GSCN research agenda reflects its capacity to collaboratively expand CTN efforts to develop
and implement innovative approaches to improve treatment for OUD and other SUDs.

Public health relevance
Project Narrative The escalating rates of opioid use disorder and overdose deaths in the United States have become a public health crisis. Expanding treatment capacity to address the opioid crisis is a national priority. The proposed Greater Southern California Node of the CTN will support the development and testing of innovative and sustainable interventions to expand treatment access and improve the effectiveness of treatment, which will lead to improved treatment outcomes and thus help address the public health crisis.